Regulatory T Cells and Pulmonary Hypertension

PROJECT SUMMARY / ABSTRACT
Clinical and preclinical studies indicate that autoimmunity and chronic inflammation, resulting from abnormalities
in regulatory T cells (Tregs), contribute to the development and progression of pulmonary arterial hypertension
(PAH). Treg dysfunction affects males and females differently and may arise because of pathogenic gene
variants and an inflamed tissue microenvironment. Treg infusion, as a cell-based therapy, restores immune
regulation, reduces vascular inflammation, and prevents animals from developing PAH. In a novel transgenic rat
model of hereditary PAH, monoallelic mutations in bone morphogenetic protein receptor 2 (Bmpr2) and lung
inflammation elicit severe disease. In these Bmpr2 mutant animals, as well as the athymic rat model of disease,
the predisposition to PAH may relate to abnormal Treg development and function. Infusion of genetically-
corrected (Bmpr2 wildtype) Tregs into Bmpr2 mutant animals, or injection of Tregs into athymic rats, restores
immune regulation, prevents vascular remodeling and ameliorates PAH. A number of Treg-infusion clinical trials
are being tested for autoimmune and inflammatory conditions and have shown early promise. Given the future
potential of Treg therapy in treating human PAH, this proposal tests the hypothesis that genetic and
environmental cues trigger Treg abnormalities that exacerbate PAH and that restoration of Treg function may be
sufficient to reverse severe disease.
This proposal investigates how genetic (BMPR2 mutations) and environmental (pulmonary inflammation) risk
factors contribute to Treg derangements and a predisposition to PAH, and how Treg infusion can limit vascular
injury and reverse PAH. Proposed studies address a previously undocumented role of BMPR2 signaling in
adaptive immune cells (i.e., Tregs). Specific Aim 1 evaluates the mechanisms by which Treg immunity in PAH
is affected by Bmpr2 mutations, chronic lung inflammation and sex-related factors. Specific Aim 1 has two
subaims which study thymic Treg development (Aim 1a) and pulmonary Treg phenotype and function (Aim 1b)
in PAH. By understanding how Treg infusion quells lung inflammation and prevents vascular injury, Specific
Aim 2 develops protocols to use ex vivo-expanded Tregs to treat established PAH. Specific Aim 2 has three
subaims which first proposes to label and track infused Tregs after adoptive transfer (Aim 2a), then to assess
Treg protective effects on pulmonary arterial vascular cells (Aim 2b), and, finally, to test the efficacy of various
Treg infusion strategies in reversing advanced PAH (Aim 2c).These studies help unify the concepts of genetic
vulnerability and immune dysregulation as related risk factors predisposing to PAH, which may offer clear
directions for future therapeutic avenues, most especially Treg immunotherapy.

Public health relevance
PROJECT NARRATIVE Uncontrolled inflammation, arising from abnormal anti-inflammatory T lymphocytes (T regulatory cells, Tregs), is implicated in a lethal cardiopulmonary condition called pulmonary arterial hypertension (PAH). This proposal seeks to understand how genetic risk factors and environmental triggers provoke Treg defects in PAH. By testing whether restoring Treg immunity reverses established PAH in experimental models, this proposal provides the foundational science to guide the design of a novel cell-based therapy for this devastating disease.